Exploring the Role of a Novel M82 Protease in S. aureus Virulence

ABSTRACT
M82 proteases are conserved across all kingdoms of life, and bear 4 catalytic motifs across 5
conserved C-terminal TMH (Transmembrane Helices), alongside a variable number of N-terminal
TMH. PrsW from B. subtilis is the founding member of the family and performs Site-1-Proteolysis
(S1P) of the σW Anti-Sigma Factor (ASF) in response to antimicrobial peptide stress. The S.
aureus homolog (prsS) is upregulated in response to DNA-damaging agents, cell wall-targeting
antibiotics, and during growth in serum and macrophages. prsS mutants display sensitivity to
DNA-damaging agents, H2O2, and cell wall-targeting antibiotics. Importantly, prsS is also required
for full virulence in S. aureus. Connected to this, a lone ECF-sigma factor, σS, exists in S. aureus.
In each regard, the expression and deletion of prsS phenocopies that for sigS, which one might
expect if PrsS is required for S1P of a σS ASF. However, despite our data tying the function of
PrsS to σS, a candidate ASF connecting the two has not been identified. It is entirely possible that
such a factor does not exist in S. aureus – there are examples of ECF σ-factors that have no ASF.
With that said, our PrsS data is strikingly similar to that for σS. Regardless, PrsS is clearly
important to the infectious potential of S. aureus, thus determining what its proteolytic substrates
are would prove highly informative. Additionally, thousands of M82 enzymes are encoded within
prokaryotic genomes, yet only a handful of studies exist characterizing them. Accordingly, in this
application we will interrogate PrsS and M82 peptidase function as follows: Aim #1 – Degradomic
Approaches to Identify PrsS Substrates: The central way one understands how a protease
contributes to cellular function is by uncovering its substrates. Therefore, in this aim we will use
unbiased and cutting edge proteomic approaches to definitively explore the complete subset of
cleavage events performed by PrsS in S. aureus. Aim #2 – Exploring PrsS (and M82) Protease
Biology: Despite the importance of PrsS, and M82 peptidases at large, our understanding of the
structural features that drive their function is sorely lacking. Accordingly, in this aim we will
undertake a structure/function interrogation of PrsS, providing detailed new insight into its role,
and much needed information on the M82 family in general.

Public health relevance
Staphylococcus aureus is a highly virulent and widely successful pathogen that is speculated to be the most common cause of human infection. With the continued emergence of multi-drug resistant isolates of S. aureus (such as MRSA), there is an urgent need to understand the mechanisms by which this deadly pathogen causes disease. This proposal seeks to explore novel proteolytic regulation of the ECF-sigma factor, σS, in S. aureus virulence.